Immune Dysfunction in HIV + Opiod Users

This Competitive Revision application for 2019 Novel Coronavirus research is related to the current grant
Immune Dysfunction in HIV+ Opioid Users (DA051202) which is investigating influenza vaccine responses in
people with HIV (PWH) who have opioid use disorder (OUD). The premise for the funded grant is that HIV
infection impairs immunity with evidence of persisting immune perturbations even after durable virologic
control. Opioids are immunosuppressive and abuse through prescription or injection can be damaging to the
immune system and prove to be specially harmful in PWH. Our central hypothesis in the parent grant is that
chronic opioid use by PWH (HIV+OP+) blunts the immune response and impairs the generation of influenza
vaccine induced immune response. Our plan is to investigate participants in 4 groups (HIV+OP+, HIV-OP+,
HIV+OP- and HIV-OP-) before and after influenza vaccine administered as a clinical trial. The project funding
started in the midst of the COVID-19 pandemic that has resulted in global morbidity and mortality. The
clinical course of SARS-CoV-2 infection is highly variable, ranging from asymptomatic to severe disease
resulting in full recovery, death, or persistent symptoms described as PASC (post acute sequalae of COVID-
19) which can affect one or more organs such as the brain, heart, lung, gut, kidneys, or musculosleletal
system. The immune response generated by SARs COV-2 is dynamic, involves innate and adaptive
immunity and evolves with the stage of the disease. Antibodies to the spike protein's receptor binding domain
corelate with neutralizing activity and form the basis of judging effectiveness of current vaccines as well as
monoclonal Ab therapy. Duration of Ab in the host following SARS CoV-2 infection or vaccination is unknown
and there are gaps in our knowledge about the role of T cells in Ab persistence or emergence of viral
variants. It is also unknown if COVID-19 causes detrimental effects on immunity and if this effect varies
depending on the host's immune competence, with the greatest impact in an immunocompromised host.
These issues are relevant for the HIV+OP+ population and need to be investigated. While Ab formation to
SARS CoV 2 is dependent upon infection or vaccination, T cell memory for SARS CoV2 has been shown to
pre-exist in approximately 50% of the general population due to cross reactive immunity induced by Common
Cold Corona viruses. Such SARS-CoV-2 specific memory T cells are considered to be beneficial to the host,
affording protection from infection, or reduction in disease severity, particularly in the face of absent or
waning humoral immunity. Despite the disruption in operations and regulatory delays due to COVID-19 our
project has been initiated, and we feel that a revision at this juncture to incorporate questions related to
SARS CoV-2 are timely and important. In this revision we are proposing to incorporate a pilot study of SARS-
CoV-2 seroprevalence and T cell memory in the context of original aims in the HIV+OP+ and the other 3
groups (HIV-OP+, HIV+OP- and HIV-OP-) being investigated for flu vaccine induced immune responses.

Public health relevance
Narrative: The novel severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) is the cause of COVID- 19, (Coronavirus disease 2019) that has resulted in global morbidity and mortality. In this study, we are proposing to investigate SARS-CoV2 seroprevalence and T cell memory responses in the opioid using HIV+ population. This is a pilot study which will help in developing more extensive proposal to determine the importance of T cell memory in immunity against SARS CoV2, and whether they have a role in affording protection from infection, or in reducing disease severity, particularly in the face of absent or waning antibodies in HIV+ chronic opioid users.